Specificity of RPSA-dependent translational control in mouse and human fetal spleen cells

Project Summary/Abstract
Ribosomopathies comprise a collection of disorders in which genetic abnormalities cause impaired ribosome
biogenesis and function. Despite the need for ribosomes in all cell types, ribosomopathies display specific clin-
ical phenotypes. Human Isolated Congenital Asplenia (ICA), which manifests at birth as absence of the spleen,
or as hypoplastic spleen, without additional developmental anomalies, has been recently classified as a ri-
bosomopathy. Given the central role of the spleen in host defense, ICA patients are vulnerable to life-
threatening blood-borne infections. Germline heterozygous mutations were identified in the gene encoding
RPSA [ribosomal protein (RP) SA; a component of the ribosome small subunit] in a large proportion of ICA pa-
tients. The critical role for RPSA in human spleen development was surprising, given that mutations in other
RPs had never been associated with asplenia. While spleen development constitutes an ideal system to study
specific functions of RPs, animal models generated so far cannot be used to determine how deficiency of
RPSA affects spleen development. Indeed, homozygosity for a null Rpsa allele causes early lethality in utero,
while heterozygosity is not associated with asplenia. In order to overcome these limitations and to identify
RPSA spleen-specific functions, we have generated mouse embryonic spleen cells with deficiency of either
Rpsa or Rps14 (of note, haploinsufficiency of RPS14 causes impaired erythropoiesis in humans, without
spleen defects). Preliminary results show that cell proliferation and protein synthesis are more strikingly re-
duced in Rpsa versus Rps14 mutant splenic cell lines. Yet, little is known about the mechanisms underlying the
specificity of RPSA-dependent phenotypes in mouse spleen cells and the potential conservation of these
mechanisms in humans. We hypothesize that RPSA plays “specialized” roles that are restricted only to spleen
development in mouse and humans. We plan to test this hypothesis via these specific aims: 1. To assess
specificity of RPSA haploinsufficiency in a tractable murine spleen model system. By using unbiased
genome-wide approaches (Ribo-seq), we will assess translation dynamics and we will measure actively trans-
lated mRNAs in wildtype and mutant (deficient for Rpsa and Rps14, respectively) mouse embryonic spleen
mesenchymal cells. These experiments will define RPSA-dependent mechanisms and translational targets that
render spleen embryonic cells more susceptible to loss of RPSA versus RPS14. 2. To assess whether RPSA
functions are conserved in a human spleen model system. We will generate and characterize human
splenic cell cultures with RPSA deficiency by performing genome editing of RPSA in splenic mesenchymal
cells obtained from human fetuses. These experiments will determine whether RPSA-dependent defects in
mouse embryonic spleen cells, identified in Aim1, are conserved in human fetal spleen cells. This research will
be ground-breaking as it will uncover unique mechanisms underpinning specific functions of ribosomal proteins
in spleen development, as well as shedding light on the pathogenesis of ICA, a life-threatening birth defect.

Public health relevance
Project Narrative Patients with Isolated Congenital Asplenia (ICA; lack of spleen) carry heterozygous mutations of RPSA, while heterozygous deletions of RPS14 are present in individuals with myelodysplastic syndrome (defective bone marrow function). We have generated murine and human spleen cell culture systems with loss of the genes encoding Ribosomal Protein SA (RPSA) and RPS14, respectively, in oder to identify specific translational targets. This research will generate new knowledge of the molecular mechanisms underlying the specific roles of ribosomal proteins in developmental processes, as well as create a platform for launching further mechanistic explorations of the mysterious pathogenesis of ICA, a life-threatening birth defect.